Regulation of hematopoiesis by ribosomal protein paralogs

PROJECT SUMMARY (See instructions):
Ribosomal proteins (RP) play crucial regulatory roles in development and disease, but the way they do so
remains unclear and is hotly debated. The regulatory functions of RP have been suggested to be mediated
through two distinct modes of action: effects at the ribosome itself, or extraribosomal functions performed
while physically separate from the ribosome. It is exceedingly difficult to definitively distinguish these modes
of action because traditional loss-of-function approaches abrogate both modes of action. Consequently, an
unequivocal determination of the contribution of extraribosomal RP functions to biological processes remains
to be achieved, and this represents a critical gap in knowledge. Filling this key gap was the subject of our
original proposal, which provided the first in vivo evidence for extraribosomal activity of an RP in controlling
development and disease. Specifically, we showed that the RP, Rpl22 is not required for ribosome
biogenesis or function, but nevertheless plays critical and selective roles in hematopoiesis while physically
separate from the ribosome, in association with the cofactor hnRNP-A1. Rpl22 is thus an outstanding
exemplar of an RP with extraribosomal functions, and examining its biology will illuminate how RP engage
in signaling pathways beyond the ribosome. We have generated mutant mice (Rp/22dN mutant) that break
the Rpl22-hnRNP-A1 interaction and these mice have revealed even more interesting findings. Specifically,
Rp/22LJN mutant mice do not display the baseline defects in hematopoiesis observed in mice lacking the
entire Rpl22 protein. Instead, these mice exhibit an inability to restrain dysplastic hematopoietic processes.
Thus, these findings provide the first evidence for a duality of extraribosomal function, where Rpl22 can act
to both promote and restrain hematopoiesis in different contexts. Consequently, we hypothesize that
extraribosomal Rpl22 exists as genetically separable complexes, one that contains hnRNP-A1 and restrains
hematopoiesis, and another of completely unknown composition that promotes hematopoiesis. As Rpl22 is
an RNA binding protein, we additionally hypothesize that each of these complexes mediate their effects by
associating with distinct pools of cellular mRNA. Our goal is to elucidate the nature of these distinct
extraribosomal complexes (Aim1) and identify the mRNA targets through which they mediate their support
and restraint of hematopoiesis (Aim2). These studies promise to provide paradigm altering insight into the
nature and mechanistic basis for extraribosomal functions in development and disease.

Public health relevance
RELEVANCE (See instructions): Gaining insight into the mechanisms by which extraribosomal Rpl22 controls HSC function will not only provide pioneering insight into how ribosomal proteins regulate biological processes, but also stand to reveal novel therapeutic entry points for acute leukemias, where the loss of Rpl22 function accelerates leukemogenesis and is linked to worse disease outcomes.